Design and testing of immunogens to elicit 10E8-like broadly neutralizing antibodies against HIV

Abstract
Induction of broadly neutralizing antibodies (bnAbs) against HIV remains a global health priority. bnAbs
targeting the membrane-proximal external region (MPER) of the HIV envelope protein (Env) offer broad
and potent protection, but their elicitation through vaccination is challenging due to the recessed epitope
close to the membrane. To overcome these challenges, we recently developed germline-targeting epitope-
scaffold nanoparticles with affinity for MPER bnAb precursors and demonstrated consistent priming of
10E8-class and LN01-class precursors in stringent mouse models and rhesus macaques. However,
heterologous boost immunizations with antigens of increasing similarity to native Env will be required to
induce bnAbs. Our strategy involves boosting with (1) epitope-scaffold nanoparticles stabilizing a
wildtype MPER, (2) membrane-bound Env stabilized in a conformation with increased MPER binding,
and (3) membrane-bound wildtype Env. Here, we propose a four-aim approach to develop an
immunization regimen that induces bnAbs by shepherding 10E8-class and LN01-class B cells. Aim 1 will
employ artificial intelligence-based computational design to develop epitope-scaffold boost#1
immunogens, Aim 2 will test these candidates in stringent mouse models, Aim 3 will utilize
computational design and mammalian display directed evolution to design stabilized transmembrane Env
boost#2 immunogens that preferentially bind intermediate 10E8-class or LN01-class antibodies, and Aim
4 will demonstrate induction of bnAbs in new intermediate BCR knock-in mice. Successful completion of
this project will be a major step in the development of an effective HIV vaccine and provide valuable
insights into the design of germline-targeting vaccines for other infectious diseases.

Public health relevance
Narrative Broadly neutralizing antibodies (bnAbs) against the membrane-proximal external region (MPER) of HIV have shown remarkable neutralizing breadth and potent protection from infection, but inducing these antibodies through vaccination has proven elusive. Our team has made significant progress in developing germline-targeting immunogens that prime rare MPER bnAb- precursor B cells in mice and macaques. This renewal proposal aims to build on our successes by iteratively refining and optimizing boosting immunogens using artificial intelligence-based computational design and stringent mouse models to induce potent bnAbs capable of protecting against diverse HIV strains.